The Role of Histone Deacetylase 9 in Vascular Calcification

Project Summary
Vascular calcification is a hallmark of atherosclerotic cardiovascular diseases such as myocardial infarction
and stroke, which are the leading causes of morbidity and mortality in the world. Although aortic calcification is
a strong independent risk factor for cardiovascular disease, the genetic determinants of aortic calcification
remain unknown and the molecular mechanisms of vascular calcification are incompletely elucidated. In a
multi-cohort study with more than 9400 participants, we identified single nucleotide polymorphisms in the
histone deacetylase 9 (HDAC9) locus that are associated with abdominal aortic calcification. In an in vitro
model of calcification, our preliminary experiments demonstrated that inhibition of HDAC9 prevented the
calcification of aortic vascular smooth muscle cells (VSMCs). In two different mouse models, we found that
global HDAC9 deficiency protected against the development of vascular calcification and atherosclerosis.
Based on our preliminary evidence, combining a human genome-wide association study, in vitro VSMC
experiments, and a murine model of vascular calcification, we have identified HDAC9 as a novel activator of
vascular calcification. The overall objective of this proposal is to understand the molecular mechanisms by
which HDAC9 promotes vascular calcification and atherosclerosis. HDAC9 is a member of the Class IIa
HDAC family, all of which possess both a deacetylase catalytic domain and a myocyte enhancer factor 2
(MEF2) binding site. First, using a series of VSMC functional assays, we propose to determine the role of
HDAC9, and its downstream target MEF2, in promoting VSMC osteogenic phenotype switch and calcification.
Second, to test the hypothesis that the influence of HDAC9 on vascular disease is exerted through its specific
effects on VSMCs, we will determine if VSMC-specific deletion of HDAC9 in a murine model is sufficient to
attenuate vascular calcification and atherosclerosis. Lastly, we have uncovered a novel interaction between
HDAC9 and the long non-coding RNA MALAT1. We will determine if MALAT1 is required for the HDAC9-
dependent effects on VSMC phenotype and on vascular calcification and atherosclerosis using a MALAT1
murine knockout model. The experiments proposed will provide important mechanistic insights into the function
of HDAC9 in the vasculature and into the underlying molecular and cellular mechanisms of vascular
calcification and atherosclerosis.

Public health relevance
Project Narrative The discovery of new and effective treatments for cardiovascular diseases requires the identification of novel disease mechanisms. This proposal aims to enhance our mechanistic insights of vascular disease by focusing on a novel biological pathway that contributes to the development of calcified arteries and plaque development in the blood vessels of humans. Success in identifying the specific molecules in this pathway implicated in the development of calcification and plaque formation will provide new potential targets for the prevention and treatment of heart attacks, stroke, and peripheral arterial disease.